Structure and functions of the actin cytoskeleton

PROJECT SUMMARY/ABSTRACT
The actin cytoskeleton is a major cellular component with key functions in virtually every aspect of cell
physiology including cell motility, shape and mechanics, cell and tissue morphogenesis, cell-cell and cell-matrix
interactions, and dynamics of membrane organelle. Aberrations in actin cytoskeleton structure, functions
and/or dynamics contribute significantly to human pathologies, especially to cancer and neurodegenerative,
immune and cardiovascular diseases. The actin cytoskeleton plays indispensable roles in cells due to its ability
to generate large pushing, pulling and resistance forces in many different combinations. To perform these
diverse functions, actin filaments are organized into diverse structural arrays by multiple accessory proteins.
Despite extensive research, the exact organization of these actin-based molecular machineries is frequently
unknown. The main barrier toward this goal is the difficulty of resolving actin cytoskeleton architecture at a
single-filament level. Without knowledge of the structure, functional understanding of the machinery is
incomplete. My lab uses a distinctive approach to overcome this problem. We take advantage of platinum
replica electron microscopy (PREM), which is uniquely able to combine high resolution imaging of the
cytoskeleton with full coverage of the whole cell and to efficiently correlate the cytoskeleton structure with live
cell dynamics. With help of PREM, my lab has made multiple fundamental contributions toward understanding
of cytoskeleton functions in a range of generic and specialized cell types. In this application, we propose in the
course of the next five years to address the following questions representing each of the four major categories
of actin cytoskeleton functions: (1) Protrusion – How microtubules regulate protrusive activity of the actin
cytoskeleton for directional migration; (2) Contraction – How an interplay between nonmuscle myosin II
paralogs regulates polarized subcellular distribution of contractile forces; (3) Cell mechanics – How differences
in the molecular architecture of the actin cortex are linked to different mechanical properties of normal and
cancer cells; (4) Membrane dynamics – How branched actin networks promote invagination of clathrin-coated
membrane domains. Our expertise in PREM in addition to a broad range of other cell biological, imaging,
functional, biochemical, and molecular biological methods puts us in unique position to significantly advance
our understanding of actin cytoskeleton functions. In turn, this knowledge may provide important new insights
into how to combat human diseases associated with actin cytoskeleton malfunctions.

Public health relevance
The results of this project will contribute to understanding molecular mechanisms of the actin cytoskeleton, a major cellular system playing critical roles in every aspect of cell physiology. Aberrations in actin cytoskeleton structure, functions and/or dynamics contribute significantly to human pathologies, especially to cancer and neurodegenerative, immune and cardiovascular diseases. Therefore, understanding of actin cytoskeleton functions will help to develop diagnostic and treatment strategies for human disease.